Biostatistics and Informatics

7. Project Summary: RC-1
The UM-OAIC Biostatistics and Informatics Core (RC-1) plays a key role in providing study design and
biostatistics support for the UM-OAIC, and for the coordination and integration of other UM-OAIC Cores in the
conduct of aging research congruent with the mission of the UM-OAIC. RC-1 serves three critical functions to
support research and research training across the UM-OAIC. 1) It serves as the information hub for the UM-
OAIC, providing the ability to track study progress, record and report adverse events, monitor core requests
and core use, and provide regular reports for project leaders. 2) It provides biostatistical and informatics
support for REC Scholars, pilot study awardees and other projects. 3) It contributes to the educational mission
of the UM-OAIC through the REC and other research training initiatives at the university.
RC-1 is led by John D. Sorkin, MD, PhD, an epidemiologist, biostatistician, and informatics expert, who
has led this Core for the last 20 years; Co-Leader Laurence Magder, PhD, a biostatistician with 35 years of
experience teaching and providing biostatistical support to biomedical research projects; and Co-Leader
Michael Terrin, MD, CM, MPH, an pulmonologist and epidemiologist with >40 years of experience in the design
and conduct of clinical trials. Co-investigators include Michelle Shardell, PhD, and Denise Orwig, PhD. The
expertise of leaders and Co-Investigators is supplemented by other contributors who bring a wide range of
significant expertise to strengthen the research of Scholars, pilot study awardees and UM-OAIC investigators.
RC-1 biostatistical support includes study design, power calculations, protocol development,
randomization of participants, statistical analysis, interim analysis, providing reports of progress to
investigators, and assistance in the preparation of manuscripts and presentations. Bioinformatics support
includes data repositories, data coordination, designing web-based data capture systems, and data
management. Bioinformatics support for the UM-OAIC infrastructure facilitates the coordination of the flow of
data from multiple investigators and laboratories that contribute to maintenance of a recruitment registry, core
request system, internal tracking database, and adverse event database for reporting to the DSMB, NIA and
regulatory authorities. RC-1 also provides support for participant recruitment and retention.
RC-1 provides mentoring and training in biostatistics to REC Scholars, affiliated faculty, and
researchers. RC-1 provides support and mentoring through Research Design Studios, Project Initiation
Support Groups and Research Working Groups. Educational and consultative services are also provided to
UM-OAIC junior and senior investigators for the design and implementation of their research. RC-1 will
promote transparency, rigor, reproducibility in research by providing mentoring and education in conjunction
with the REC and PESC. RC-1 also will develop new and innovative statistical methodology to assist UM-
OAIC scientists in the performance of their research.